IGF::OT::IGF logistical support services for meeting titled, "Third Circulation: Lymphatics as Regulator of Health and Disease"

logistical support services for meeting titled, Third Circulation: Lymphatics as Regulator of Health and Disease